Res-Ed Component

The CICADA Research Education Component (REC) will provide mentoring and research training to
RCMAR Scientists from underrepresented backgrounds in health services research (HSR) and aging. The
long-term goal of the REC is to expand the number of underrepresented faculty with successful careers
conducting independent research to advance and improve the delivery, organization, and financing of
health care for aging populations. We will target three categories of trainees to become RCMAR
Scientists: (1) MD and MD/PhD clinical fellows who have completed their residency, (2) PhD
postdoctoral trainees, and (3) MD/PhD, MD, and PhD junior faculty [defined as Instructor or early-stage
(<3 years) Assistant Professor]. To help build our pipeline of promising researchers, we will also engage
in targeted efforts to identify undergraduate and graduate students from underrepresented groups to
participate in mentored research experiences—e.g., during a summer semester or research block.
The CICADA REC will select three new RCMAR Scientists each year through a competitive call for pilot
grants. Each RCMAR Scientist will conduct a 1-year pilot research project supported by the CICADA REC
through pilot research funding and high-quality, intensive mentoring by established Penn health services
researchers focusing on health care delivery for aging populations and, in particular, disparities in care.
Mentors will have experience in guiding and nurturing developing investigators, including those from
groups that are underrepresented in HSR in aging. Once the RCMAR Scientists have completed their 1-
year pilot project, they will remain a part of the CICADA community and continue to benefit from
CICADA’s research training and support, as the REC is committed to developing RCMAR Scientists into
successful independent researchers in HSR for aging populations.